ShEEP Request for Sensorimotor Dynamic Response Measurement System

Falls are by far the leading cause of accidental injury and death in older adults. The Veteran population
is more severely affected by falls since it is significantly older than the overall population (45% over 65 years of
age vs. 13%); and Veterans would benefit substantially more from an accurate diagnosis and treatment of
balance deficits and fall propensity. Despite its importance, much is still unknown about the manner in which
balance control is compromised by age and disease. This is a proposal to acquire a Sensorimotor Dynamic
Response Measurement System (SDRMS) from Government Scientific Source, Inc. to measure signal
processing delays, transmission delays, and the neural noise associated with the four feedback sensorimotor
pathways involved in standing and walking balance, the resulting feedforward motor signals to the
musculature, and the response dynamics of the associated musculature.
Human balance is controlled and maintained by numerous interacting sensorimotor and
musculoskeletal elements, organized into an adaptive feedback control loop. These elements communicate
with one another via neural signals, and the quality of these signals constitutes an important, largely
overlooked aspect of this loop’s performance. Aging, associated morbidities, and injuries not only cause the
elements within this loop to deteriorate; they also increase the delays and noise associated with their neural
signals. Increased transmission delays and noise will in themselves degrade balance system performance
and can cause such a system to fail if they become excessive. Despite its significance, balance-related
transmission delays and noise have rarely been measured and investigated in a comprehensive and
systematic manner. The SDRMS addresses this gap. This information is valuable for studying vulnerable
Veteran populations in that it provides quantitative measures of an individual’s balance capability. Proper
assessment of the sensory function in balance requires that each modality be isolated from the others and
tested independently (to prevent the confounding effects of sensory system redundancy) to determine the
accuracy and sensitivity with which it detects its associated stimulus; the speed with which its signals reach
the higher level processing centers of the brain, and the noise associated with its signal. The SDRMS then
measures the speed with which the motor centers of the brain communicate muscle activation commands to
the musculature, the noise associated with these signals, and the muscles’ resulting activation dynamic
response. These measures can be compared with those of young healthy individuals with no deficits to
quantify the degree of deterioration brought on by age, disease, and injury; and to track changes in balance
capability over time. The system can also identify the relative contribution of specific balance system
elements and the neural signals they transmit to this deterioration.
Government Scientific Source, Inc. will deliver the integrated system. Assessment by the SDRMS
occurs in five phases corresponding to each of its five modules. Though the modules are employed in
sequence, they share individual components. Thus, it would not be possible to “break the system apart” and
employ the modules as separate measurement systems. Moreover, though the individual sensory modalities
and feedforward pathways are tested in isolation from one another, it is important that all the assessments be
conducted contiguously, as the balance system can adapt and change in subtle ways over time.

Public health relevance
The prevalence of fall-related injury and death are greater in the Veteran population due to a higher prevalence of disability. Many clinical balance tests are unable to identify the underlying physiological mechanisms responsible for diminished function. Such a capability would enable therapeutic interventions to be tailored to specific deficits, increasing their efficacy and cost-effectiveness—a long term objective of our research. The objective of this proposal is to acquire such a system to facilitate research in the diagnosis and treatment of balance deficits resulting from age, disease, and injury. Human balance is controlled and maintained by numerous interacting sensorimotor and musculoskeletal elements, organized into an adaptive feedback control loop. The Sensorimotor Dynamic Response Measurement System (SDRMS) measures the signal processing and transmission delays, muscle activation dynamics, and neural noise associated with this loop - providing quantitative measures of the deterioration of an individual’s balance capability over time.